Fred & Pamela Buffett Cancer Center Support Grant

Project Summary/Abstract: Overall
The Fred & Pamela Buffett Cancer Center (Buffett Cancer Center or FPBCC) at the University of Nebraska
Medical Center is committed to developing new strategies for the treatment and prevention of cancer through
innovative interdisciplinary research, premier educational programs, the highest quality patient care, and
outreach to underserved populations. The Buffett Cancer Center is dedicated to reducing the burden of
cancer through interdisciplinary translational cancer research leading to new therapies for cancer treatment as
well as enhancing the well-being of cancer survivors. As the only NCI-designated Cancer Center in
Nebraska, we are very sensitive to the needs of the underserved populations in our catchment area (across
the state of Nebraska and western Iowa), including women, minorities and children as well as the medically
underserved rural residents in our region. The 84 members of the Buffett Cancer Center are actively involved
in the interdisciplinary FPBCC Research Programs including the Molecular and Biochemical Etiology
Program (MBEP), the Cancer Genes and Molecular Regulation Program (CGMR), and the
Gastrointestinal Cancer Program (GICP). The FBPCC is a matrix with Members in each of the Colleges and
Institutes at UNMC, as well as Members at the University of Nebraska - Lincoln and the University of Nebraska
- Omaha. The FPBCC Director also leads the Eppley Cancer Institute, with 30 tenure/tenure-leading faculty
appointments. The FPBCC Director reports directly to the Chancellor of UNMC and serves on the UNMC
Chancellor's Council and the Nebraska Medicine's Senior Leadership Team, the two most senior and
responsible cabinets of the the academic and the clinical enterprise. A new $323 M Buffett Cancer Center
(625,000 gsf) will open in 2017 integrating cancer research and care in one facility and provide ample room
FPBCC growth. Since the last review, the FPBCC enhanced interdisciplinary research collaborations by
providing support for recruitment of 30 new Members (including the co-leaders of the GICP and the Director of
the Bioinformatics Shared Resource), for enhancements to shared research facilities, and for pilot funding
for collaborative multidisciplinary research projects. The FPBCC has a robust track record of transdisciplinary
cancer research and strong evidence of collaborations bridging all of the Research Programs. Buffett Cancer
Center research has resulted in 1409 publications of which 23% are inter-programmatic collaborations, 23%
are intra-programmatic collaborations and 9% are both. FPBCC externally funded cancer research portfolio
which currently exceeds $34.3 M annually in peer-reviewed support (> 46% NCI) demonstrates university-wide
transdisciplinary cancer research collaborations by Buffett Cancer Center Members focused on resolving
cancer-related problems.

Public health relevance
Project Narrative: Overall The mission of the Fred and Pamela Buffett Cancer Center (FPBCC), formerly known as the UNMC Eppley Cancer Center, is to understand, prevent and cure cancer in Nebraska through premier educational programs, innovative research, the highest quality patient care, and outreach to underserved populations.